Investigating Placental EFA metabolism in GDM through Integrative spatial multiomics

The prevalence of gestational diabetes (GDM) is increasing in association with more adverse pregnancy
outcomes and greater risk of development of type 2 diabetes in later life. GDM is associated with many fetal and
newborn complications and programming of offspring for development of obesity and diabetes. A male fetus is
at greater risk of adverse outcome than a female fetus perhaps related to the sexual dimorphism in placental
gene expression, placental inflammatory, hypoxia and apoptotic responses, antioxidant defenses, miRNA
expression and mitochondrial dysfunction. Placental mitochondria are the main source of ATP required to power
peptide hormone production, nutrient uptake and transfer and are central to generation of oxidative stress and
inflammatory responses. Placental mitochondrial respiration is reduced with the hyperglycemia,
hyperinsulinemia and hyperlipidemia of obesity and GDM together with altered fuel flexibility where male but not
female trophopblast lose flexibility to switch between use of glucose, fatty acids and glutamine. Lipidomic
analysis showed male but not female placentae from GDM had a significantly lower proportion of
docosahexaenoic acid (DHA)-containing triglycerides (storage lipids) vs lean or obese placenta. DHA is an
essential fatty acid crucial for fetal brain development but also important for membrane structure/function,
reducing oxidative stress and inflammation and regulating mitochondrial function, hence there is a need to define
DHA actions in the male vs female placenta and if these are affected with obesity and GDM. Using proteomic
analysis, GDM male placentae showed significant downregulation vs lean male placentae of pathways related
to protein synthesis and upregulation of inflammatory pathways. In contrast female GDM placentae showed
downregulation, vs lean and obese, of pathways related to glucose metabolism. Hence, we have a strong
premise to determine the mechanisms underlying the sexual dimorphism of cellular response to the GDM milieu
in placenta and particularly if DHA has a central role in this. Our previous `omic' work was on whole placental
villous tissue, obscuring the spatial localization of signals. We have developed a metabolome-informed proteome
imaging (MIPI) workflow where MALDI-MSI allows multi-modal imaging of 12μm placental villous tissue sections,
showing regions of differing metabolic activity and complementary proteome profiling of mapped regions
captures region-specific enzymes and highlights functional differences between syncytiotrophoblast and villous
core compartments. We will employ the MIPI technology on tissue sections and also employ trophoblast cultures
of male and female placentas of lean and obese women each with or without type A2GDM pregnancies to test
the hypothesis that there is sexual dimorphism in the setting of maternal obesity and GDM in cellular pathways
and mechanisms involving trophoblast mitochondrial function, protein homoeostasis, oxidative stress,
inflammation and insulin resistance regulated by the essential fatty acid DHA, This technically and conceptually
innovative work may lead to establishment of fetal sex-specific therapeutic approaches in such pregnancies.

Public health relevance
Narrative: The prevalence of gestational diabetes (GDM) is increasing leading to greater risk of development of type 2 diabetes in later life and programming of offspring for development of obesity and diabetes. We recently found decreased placental content of triglycerides containing the essential fatty acid docosahexaenoic acid (DHA) in male vs female placenta with GDM associated with increased expression of gene pathways associated with inflammation but decreased expression of pathways associated with protein synthesis in males whereas female placentas showed downregulation of pathways related to glucose metabolism. We will use a novel metabolome informed proteome imaging (MIPI) technique to spatially localize placental DHA metabolism and use primary human trophoblast culture to define mechanisms whereby DHA regulates placental mitochondrial function, oxidative stress, inflammation and protein homeostasis in the setting of obesity and GDM in a sexually dimorphic manner potentially leading to fetal sex-specific therapeutic approaches.